Biomarkers and subphenotypes predictive of clinical outcomes in patients with COVID-19 related acute respiratory distress syndrome

PROJECT SUMMARY/ABSTRACT
Acute Respiratory Distress Syndrome (ARDS), caused by a variety of triggers including COVID-19, is a
devastating critical illness without effective therapies. Despite numerous studies on COVID-19 related ARDS
(CARDS), the best available treatments lead to only modest or inconsistent clinical improvements. This paucity
of discoveries is likely in part due to heterogeneity of host response to COVID-19. The long-term goal is to bring
precision therapies to patients with ARDS and CARDS. Using plasma protein biomarkers and clinical data, Dr.
Calfee (sponsor of the applicant) has identified two biologic subphenotypes of non-COVID-19 related or “typical”
ARDS. Specifically, patients with the hyperinflammatory subphenotype had higher levels of inflammatory
biomarkers, metabolic acidosis, and shock. They also experienced significantly higher mortality and were more
likely to benefit from certain ICU therapies. Conversely, most CARDS patients demonstrate a hypoinflammatory
subphenotype of typical ARDS, raising questions about the pathophysiology underlying poor outcomes in this
population. The overall objective of this project is to (i) identify plasma biomarkers and differential gene
expression associated with poor outcomes in CARDS and (ii) search for the presence of CARDS specific
subphenotypes of clinical importance. The central hypothesis is that differential gene expression indicative of
dysregulated inflammation and high baseline plasma biomarkers of lung injury and disordered coagulation will
predict poor outcomes in CARDS, and that distinct CARDS subphenotypes exist associated with differential
outcomes and treatment responses. The rationale for this project is that it will offer mechanistic insights into the
biology underlying poor outcomes in this population, lead to identifying potential druggable targets, and identify
patients most likely to benefit from targeted therapies. The central hypothesis will be tested by pursuing these
specific aims: 1) Identify biological predictors of poor clinical outcomes within patients with CARDS; and 2)
Identify distinct biologic subphenotypes of CARDS associated with poor clinical outcomes and differential
treatment response. Under aim 1, hypothesis-driven plasma protein biomarkers will be measured, and RNA
sequencing performed on blood samples of CARDS patients enrolled in ISPY COVID, an ongoing adaptive
randomized controlled trial of experimental drugs across multiple US institutions. Under aim 2, latent class
analysis will be performed on a combination of protein biomarkers and clinical variables to identify
subphenotypes associated with distinct outcomes and responses to the trial’s investigational agents. The
proposed research is innovative, because extensive biological phenotyping in a large and representative cohort
of patients with a uniform trigger for ARDS has not been done and may be the key to identifying successful
therapies. Ultimately, this knowledge will pave the way for conducting phenotype-aware trials studying targeted
therapies in patients with subphenotypes of CARDS.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on phenotyping patients with COVID-19 related acute respiratory distress syndrome (CARDS), a devastating critical illness that has caused over 700,000 deaths in the United States alone since 2020 and for which effective therapies are currently limited. Phenotyping CARDS patients to identify those at highest risk of poor outcomes and most likely to benefit from targeted therapies will lay important groundwork for future phenotype-aware trials in COVID-19 and non-COVID-19 related ARDS. This proposal responds to a Critical Challenge laid out by NHLBI’s Strategic Vision to use phenotyping to promote the discovery of druggable targets and enable novel and precise treatments for lung diseases.